Improving Models of Alcohol Consumption Mismeasurement and Burden of Disease

PROJECT SUMMARY/ABSTRACT Alcohol is a contributing factor for a number of diseases, including many cancers, and evidence suggests that there are substantial medical and economic costs associated with alcohol-attributable disease incidence. However, the current evidence base suffers from two weaknesses. First, estimating alcohol- attributable disease incidence requires accurate measurements of the prevalence of alcohol exposures, and the surveillance data sources researchers use to measure the prevalence of alcohol exposures are likely error prone. Second, most studies that estimate alcohol-attributable disease incidence and corresponding medical and economic costs focus on the incident cases and costs that could be avoided if no one in the population consumed alcohol, which is an unreasonable alcohol reduction target. This study will address these two weaknesses by first developing a new, Bayesian approach for estimating the prevalence of alcohol exposures from self-report survey data and then applying this approach to a novel study of the potential impacts on burden of illness and corresponding economic costs that could occur if modest reductions in alcohol use were achieved across different subgroups (e.g., based on drinking frequencies and demographics). Thus, this study will produce valuable methodological advances and new evidence that will better inform how best to adopt public health strategies for reducing the burden and cost of illness associated with alcohol use.

Public health relevance
PROJECT NARRATIVE The proposed study will develop a more general, flexible method for reducing bias in burden of illness studies due to underreporting of alcohol consumption that will support more accurate comparisons of the impacts of policies and interventions for reducing population exposure to alcohol and thereby reduce the burden and cost of cancers attributable to alcohol. This will be accomplished by first developing a Bayesian model to improve previous triangulation methods of adjusting for underreporting and then applying this distribution and approach to investigate the potential impacts on burden and cost of cancers attributable to alcohol that could be achieved by reducing alcohol use among different subgroups based on drinking frequency and demographics. Such an approach will reduce bias by using information on underreporting from “gold standard” alcohol measurement studies to estimate a national distribution of alcohol exposure.